Opportunistic use of existing chest CT data for frailty screening

PROJECT SUMMARY
I am an early-stage clinician investigator and an advanced multi-modality imaging cardiologist at the Icahn
School of Medicine at Mount Sinai. My goal is to become a leader at the intersection of aging, cardiovascular
imaging, and cardiovascular disease. My work focuses on how best to deliver patient-centered care and
improve outcomes of older adults through use of cardiovascular imaging for stable ischemic heart disease
(SIHD). Assessment of frailty is one key tool to improve these outcomes, as one in four of the 10 million older
adults in the U.S. with SIHD is frail. Frailty is associated with increased risk of complications, hospitalizations,
health care costs and mortality among patients with or without SIHD. Unlike most geriatric syndromes, frailty
can be reversed with targeted interventions if diagnosed early and can guide personalized treatment decisions.
Yet, frailty is rarely assessed in clinical practice due limited time and resources, or unfamiliarity with screening
tools. This may lead to clinicians withholding appropriate beneficial treatment options for certain patients or
subject other patients to inappropriate treatments that increase harm with limited benefit. Novel frailty
screening tools that overcome these barriers are critical to increase frailty screening in clinical practice.
The opportunistic use of existing imaging data acquired for other clinical indications is an innovative
application for frailty measurement. These imaging data are ubiquitous: majority of the more than 1.5 million
stress nuclear myocardial perfusion imaging (MPI) studies performed annually in older adults for diagnosis and
management of SIHD also acquire low-dose chest CT images to improve image quality and diagnostic
performance. In this project, I will develop and validate a novel chest CT-based frailty screening tool using
artificial intelligence (AI) assisted multi-organ body composition information available from existing chest CT
data performed with stress MPI. Next, we will compare the prognostic performance of the new CT-based tool
with a validated electronic health record-based electronic frailty index to predict healthcare utilization and
death. Finally, we will adapt this screening tool for integration within routine clinical workflow, and pilot test its
feasibility using a pre-post approach among older adults presenting to an outpatient cardiology clinic visit for
clinical decision making after stress imaging. The results of our study will integrate novel frailty screening into
routine cardiovascular practice, to help guide patient-centered treatment decisions, target effective prevention
strategies, and inform my future R01, which will test AI-enhanced patient evaluation strategies among older
adults. This Beeson award will support my training in (1) geriatrics and geriatric cardiology; (2) clinical
applications of AI (3) dissemination and implementation science and (4) leadership. Our approach can expand
the availability of real-time point-of-care frailty screening without additional clinical burden by using existing CT
data. The Beeson award will help me achieve my goal to become a leader in aging who develops novel
strategies aligning imaging use with the distinct needs of older adults with SIHD.

Public health relevance
PROJECT NARRATIVE Frailty assessment in older adults is critical to guide patient-centered treatment decisions and target effective primary and secondary frailty prevention strategies. Despite multiple frailty measures, frailty is rarely assessed in clinical practice due limited time and resources, or unfamiliarity with screening tools. The overall objective of this study is (1) to develop and validate a novel chest CT-based frailty screening tool with the opportunistic use of existing chest CT data, (2) to compare the performance of this imaging-based frailty tool with validated electronic health record-based frailty assessment in predicting healthcare utilization and death among patients with stable ischemic heart disease and (3) pilot test the feasibility of integrating this novel tool in practice.